Rapid Response Team (RRT) Maintenance TrackMichigan Department of Agriculture and Rural Development (MDARD)

MI RRT Project Summary RFA-FD-23-019
The Michigan Department of Agriculture and Rural Development (MDARD) is the lead state
agency for both food and feed safety with authority to oversee all the segments of the farm-to-
consumer continuum. Michigan’s over-arching goal and vision is to maintain high-quality food
and feed regulatory programs while continuing to enhance MDARD’s multi-disciplinary, multi-
divisional capacity to respond to food and feed issues within the agency, while improving
effective working relationships with the FDA (ORA OHAFO HAFE6), Michigan Department of
Health and Human Services, Michigan’s 45 local health departments, academia, industry, and
other stakeholders.
The RRT Maintenance funding opportunity will allow Michigan to continue improving its
capabilities to help advance the nationally integrated human and animal food safety system by
continuing to strengthen the link between epidemiology, laboratory, environmental health, and
regulatory activities; to expand use of Incident Command System principles during responses to
all-hazard emergencies; strengthen Michigan’s regulatory inspection and sampling of human
and animal food safety programs by rapidly identifying and removing unsafe food or feed from
the marketplace and conducting root cause investigations to influence future prevention efforts;
and enhance key components that support the RRT, such as training, communication, data
sharing, data analysis, continuous process improvement, and development of best practices
and other resources to support national response capacity and capability development.

Public health relevance
MI RRT Project Narrative RFA-FD-23-019 The RRT Maintenance funding support will allow Michigan the opportunity to continue enhancing the MI RRT’s integrated strategy for a sustained, multidisciplinary, multi-agency approach to protect human and animal health through food and feed safety efforts. The Michigan Department of Agriculture and Rural Development (MDARD) has, given the diversity and scope the food and agricultural infrastructure, demonstrated that rapid response capacities for food and feed emergencies are best developed through the active engagement of individuals and task forces with a wide range of expertise to protect public health, the environment, and the economy. MDARD’s compliance and conformance with the Manufactured Food Regulatory Program Standards (MFRPS) and the Animal Food Regulatory Program Standards (AFRPS) provides a solid foundation for the MI RRT and help advance Michigan’s efforts to improve consistency and uniformity with federal standards and other state RRT programs; maintain the highest-quality investigation work; establish a basis for measuring and improving performance; share data and investigational findings with partners and industry; and develop and share best practices and other resources to support state and national response capacity and capability development to improve and influence the nationally integrated food safety system protection efforts.